Early-Phase Psychosis: Practice-Based Research to Improve Treatment Outcomes-Administrative Core

Project Summary/Abstract
The overall goal of the ESPRITO Administrative Core is to support and improve CSC care and outcomes
for LHS participants. The Core activities build on the success of the current ESPRITO in LHS enrollment
(963) and CAB completion (2,600). It will provide the home for a range of critical CSC and LHS functions.
It will be the base for leadership and linkage to the ENDCC and NIMH EPINET. The Program Project PI,
Delbert Robinson will serve as PI of the Core and will serve on the EPINET Research Consortium. An
Executive Committee will develop policy and review ongoing progress quarterly. A Core Operations
Team led by Dr. Robinson will include the leadership of Research Projects and other Key Personnel. It
will meet biweekly. This will allow the group to provide close coordination with the Operations Group led
by Patricia Marcy that is responsible for direct interaction with our 13 sites and all reporting to the ENDCC
that includes CABs, raw data and data analyses from our Research Projects. The Operations Group will
also work to link site clinicians to dashboards developed by Clinical Informatics that are tailored to support
measurement-based care with NAVIGATE, the CSC that all ESPRITO sites provide. This structure is
designed to address EPINET requirements and profits from the extensive experience of the ESPRITO
team in research with First Episode Psychosis (FEP), research and delivery of services in community
clinical settings that provide CSC and almost five years of work in the current EPINET initiative. Our
Prospective Practice-Oriented Research Project: Predicting hospitalization and disengagement with
automated speech and language analysis and our Clinical Practice Research Project: Enhancing Patient
Engagement in LHS Participation and in CSC Treatment are linked by providing complementary
approaches to addressing disengagement. They also depend on the Administrative Core. For our
automated speech and language analysis, the Operations Group will manage participant recruitment and
retention as well as data collection. The Clinical Practice Research Project to enhance patient
engagement takes advantage of CAB data and iterative interaction with sites and NAVIGATE clinicians
that requires active engagement with the Operations Group. The Administrative Core also includes a
statistics group that will apply innovative approaches to analyses of CAB data that are designed for
communication to clinicians to support improved outcomes. ESPRITO sites span the US and are also
diverse in terms of social determinants of health. We will employ multiple statistical approaches to
understanding this diversity. Finally, Administrative Core leadership will use multiple methods including a
learning collaborative to develop and nurture the next generation of leaders in providing CSC services
and the future research that will be needed to ensure that the LHS model can continue to evolve and
improve.